Advances in Nanomedicine Symposium at the 236th National Meeting of the American

[unreadable] DESCRIPTION (provided by applicant): The goal of this multidisciplinary symposium will be to discuss nanomaterials or nanotechnology-enhanced modalities with strong potential for translation into clinical research. Cancer nanotechnology will be a major theme throughout the symposium. [unreadable] [unreadable] The symposium will be divided into three categories: [unreadable] [unreadable] (i) Nanomaterials and surfaces for tissue engineering [unreadable] [unreadable] (ii) Multifunctional nanoparticles for targeted imaging and therapy (theragnostics) [unreadable] [unreadable] (iii) Nanomaterials for drug delivery [unreadable] [unreadable] [unreadable] [unreadable]